Establishing Genotype-to-Phenotype Relationships Between Alzheimer’s Related BIN1 Variants

PROJECT SUMMARY ABSTRACT
Genome-wide association studies (GWAS) have identified several risk factors associated with altered probability
of late onset Alzheimer’s disease (LOAD). In this regard, variation in bridging integrator 1 (BIN1) have been
identified as being strongly associated with increased risk of AD. To that end, several preliminary studies have
suggested that BIN1 not only modulates amyloid and tau pathology but also modulates various inflammatory
and cell homeostatic pathways. Nonetheless, the mechanistic links between BIN1 and AD remain poorly defined.
Moreover, there is a paucity of research examining the effects of BIN 1 variation on the manifestation or
augmentation of AD-related phenotypes. In this proposal, we will use our collective expertise in stem cell
bioengineering, neurodegenerative disease modeling, and genome engineering to investigate the relationship
between specific BIN 1 variants and AD risk. In the first aim, we will using our highly efficient gene editing
approach to introduce BIN1 variants into isogenic hiPSCs from healthy non-demented control (NDC) and AD
patients. In the second aim, we will employ isogenic hiPSC lines in a 3-D co-culture model to test the hypothesis
that these BIN variants exert their risk-modifying effects through (i) modulation of amyloid precursor protein
(APP) processing and Aβ secretion and (ii) alteration in tau hyperphosphorylation and internalization. In addition,
we will use RNA-seq analysis to identify signaling pathways, gene regulatory networks, and transcriptional
targets that are independently influenced by the presence of BIN variation and disease status. In addition,
through the use of BIN1 knockout hiPSCs we will be able to determine if these BIN1 variants induce their effects
occur through gain- or loss-of-function mechanisms. Overall, a more thorough understanding of the mechanisms
by which variation in BIN1 contributes to the likelihood of AD onset will have a significant impact on the design
of therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Variation in the bridging integrator 1 (BIN1) gene has been identified as one of the strongest genetic risk factors associated with Alzheimer’s disease (AD). As such this proposal seeks to use a unique combination of human- induced pluripotent stem cell (hiPSC)-based models and genome editing strategies to elucidate the relationship between BIN1 variants and AD risk. This research will significantly advance our understanding of the complex genetic interaction that modulate AD onset.